Ketosis as a therapy for polycystic kidney disease

Project Summary/Abstract We have previously shown that a mild reduction in food intake strongly inhibits progression of polycystic kidney disease (PKD) in an orthologous mouse model but we did not understand the mechanism. Now, we discovered that the metabolic state of ketosis is important, not caloric restriction per se. Dietary interventions leading to ketosis profoundly inhibit - and even reverse - PKD progression in orthologous and non-ortholgous mouse, rat and feline models of PKD. Remarkably, treatment with the ketone β-hydroxybutyrate (BHB) alone is almost 100% effective in preventing PKD progression. Preliminary results suggest that BHB acts on PKD kidneys via its receptor GPR109a, a GPCR that suppresses cAMP signaling. Our results suggest that cyst cells in PKD are metabolically inﬂexible, depend on glucose and are unable to shift to utilizing fatty acids and ketone bodies. The main thrust of this proposal is to generate compelling results to justify clinical trials to investigate the efﬁcacy of dietary interventions and/or BHB supplementation in ADPKD, and to inform the design of such trials. The main signiﬁcance of this proposal is the enormous potential for clinical translation. Dietary interventions to induce ketosis are well-established. Because dietary interventions frequently fail in clinical practice due to poor adherence, our ﬁnding that BHB (an FDA-classiﬁed dietary supplement) has a dominant beneﬁcial effect could rapidly lead to a highly feasible therapy. To achieve our goals, we will treat rodent and feline models of PKD, with dietary interventions to induce ketosis (time-restricted feeding or ketogenic diets) or mimic ketosis by supplementation with BHB. Efﬁcacy on parameters of PKD progression and effects on molecular mechanisms will be assessed. To determine whether BHB acts via GPR109a, we have crossed Gpr109a-/- mice with fast- and slowly-progressing Pkd1 mouse models. We will test whether Gpr109a knock-out affects disease progression and prevents the efﬁcacy of ketogenic dietary intervention or BHB. Successful completion of the proposed work could lead to a disruptive change in ADPKD therapy by utilizing dietary interventions and/or dietary supplements without the need for pharmacological intervention.

Public health relevance
Project Narrative We have discovered that the metabolic state of ketosis profoundly inhibits - and even reverses - the progression of polycystic kidney disease (PKD) in animal models. Inducing ketosis with dietary interventions or mimicking it by administration of the natural ketone body β-hydroxybutyrate (BHB) all proved highly effective in inhibiting renal cyst proliferation and ﬁbrosis. Here, we propose to identify the most effective treatments and study the underlying mechanisms in order to be able to design a future clinical trial to test the efﬁcacy of dietary interventions and/or treatment with BHB, an inexpensive and safe compound that is FDA-classiﬁed as a dietary supplement.